mHealth Technology to Connect and Empower People Experiencing Homelessness to Improve Health and Social Need Outcomes

PROJECT SUMMARY/ABSTRACT
People experiencing homelessness (PEH) are at exceptionally high risk of frequent emergency department
(ED) and hospital use, poor functional outcomes, and increased morbidity and mortality from poorly managed
chronic health conditions and complex social needs. Significant deficiencies in continuity of care and poor
communication between PEH and health and social services providers contribute to these bleak long-term
outcomes. Evidence-based interventions of particular promise for reducing ED and hospital utilization and
improving health outcomes and meeting social needs involve: 1) providing care in the community to overcome
barriers including transportation and fear of stigmatization; 2) coordination of care transitions following ED or
hospital discharge to improve access to needed community supports and reduce the risk of readmission; and
3) using mHealth technology to link PEH with appropriate community-based health and social services. This
project will build on evidence from two feasibility studies in order to integrate and test a mHealth intervention,
comprised of global positioning system technology and text messaging components, into a community setting
to connect PEH with a community-based case manager and healthcare and social services. Our hypothesis is
that integrating the mHealth intervention into an established, trusted navigation center for PEH will mitigate
barriers to care and gaps in the care continuum resulting in decreased ED and hospital use and improved
health outcomes and attainment of social needs. Our specific aims are to: 1) refine the existing mHealth
intervention and implementation strategy using a community-based participatory research approach; 2)
conduct a stratified RCT to compare a mHealth intervention with usual care community-based case
management to examine the impact on healthcare utilization (primary outcome), medication adherence, social
support, psychological distress and social needs attainment (secondary outcomes) in PEH; and 3) identify and
understand factors from PEH and stakeholder perspectives that impact sustainability of the mHealth
intervention. The project will be conducted in four phases. During phase one, we will refine the intervention
(Aim 1) by eliciting feedback from PEH, key informants, and our community advisory board before conducting
a usability test of the refined mHealth intervention. Phase two will consist of the RCT (Aim 2) to compare the
efficacy of the mHealth intervention to a usual care control group. Phase three will identify factors to facilitate
sustainability of the mHealth intervention (Aim 3) using stakeholder interviews. Phase four will consist of data
analysis, triangulation of findings, and dissemination. This study is significant and innovative for several
reasons: targets an AHRQ understudied group with complex needs and use of high cost services at a critical
transition point; is based in a community-based navigation center instead of a traditional health or social
services setting; and recognizes the need for end-user engagement in design.

Public health relevance
PROJECT NARRATIVE People experiencing homelessness (PEH) are at high risk for emergency department and hospital use due to gaps in care and poor communication between health and social services providers. This study will integrate and test a novel mHealth intervention, comprised of global positioning system technology and text messaging components, into a community setting in order to connect PEH with healthcare and social services. This research is significant in that it will engage end-users in refining and integrating the mHealth intervention with a community-based navigation center and employ a RCT design to test the impact of the intervention on ED and hospital visits and health and social needs outcomes.